Dissecting the Role of Mechanical Forces in the Branching Morphogenesis of the Mouse Bronchial Tree

PROJECT SUMMARY
Lung development requires a tight interplay between the pulmonary epithelium and the surrounding mechanical
environment, including the airway smooth muscle (ASM) and the thoracic cavity. Defects in the mechanical
environment of the embryonic lung, such as congenital diaphragmatic hernia (CDH), are associated with
pulmonary hypoplasia leading to significant mortality and morbidity. Therefore, it is necessary to investigate the
role of the mechanics on lung development. The central objective of this proposal is to characterize the effects
of the mechanical environment on the spatial and temporal patterns of branching morphogenesis in the lung.
Mechanical forces have been thought to play a role in branching morphogenesis of the embryonic lung for
decades, but a detailed understanding has been limited by the experimental challenge of simultaneously
manipulating and observing lung development in a physiologically relevant setting: studies in vivo are limited by
the inaccessibility of the lung in the embryo, while those in culture restrict lung explant growth to a non-
physiological, flat surface. Nonetheless, recent innovations in microfluidic approaches support physiologically
relevant lung development ex vivo and enable tracking of branching morphogenesis under various applied
pressures. Studies using these approaches have revealed a tight coupling between transpulmonary pressure,
ASM contractions, and the rate of lung branching. The overall hypothesis of this proposal is that branching in the
lung is driven by a pressure-dependent ‘clock’ of ASM contractions. To test this hypothesis, I will combine a
mouse model of CDH, whole-mount immunostaining, quantitative imaging and analysis, and a microfluidic
culture model to track the development of lungs under various mechanical perturbations. First, I will determine
whether the mechanical stimulus of ASM contraction is sufficient for inducing lung branching events. Second, I
will define the progression of lung development in a mouse model of CDH and assess the role of local changes
in pressure on branching rates in lungs cultured ex vivo. Collectively, the findings of this proposal will provide
detailed insight into the function of ASM contractions and compressive forces in a physiologically relevant setting
amenable to fine perturbations. These results will have a broad impact on understanding the physical forces that
sculpt lung development and will provide original insights that will help guide strategies for treatment of prenatal
lung hypoplasia. The activities proposed here will enhance my ability to conduct experiments and data analysis
and to communicate research to a broader audience. These activities will also offer opportunities to teach and
mentor emerging scientists. I will leverage the analytic skills acquired during my undergraduate training and
expand my aptitude in bioengineering and mechanobiology by making use of the world-class expertise and
extensive resources that my supervisor (Dr. Celeste Nelson) and Princeton University have to offer. These
activities will help me become an independent researcher and will provide a robust foundation for establishing
my own research direction investigating the determinants of multiscale coordination in tissue morphogenesis.

Public health relevance
PROJECT NARRATIVE Lung development requires a tight interplay between the pulmonary epithelium and its surrounding mechanical environment, including the airway smooth muscle and the pleural cavity. The proposed research will test the hypotheses that airway smooth muscle contractions set the pace of branching events in a pressure- dependent manner, and that both smooth muscle contraction and branching dynamics are modulated by local compressive forces. Upon completion, the findings from this proposal will reveal the role of airway smooth muscle contractions in lung branching morphogenesis and help guide the creation of mechanical therapies for mitigating fetal lung hypoplasia.